Investigating the impact of APOE on cerebral energetics

Project summary
Despite great advances in understanding the pathogenesis of Alzheimer's disease and its related
dementias (ADRD), effective treatments still remain elusive and most promising therapies have failed to
translate from animal models into humans. While cerebral hypometabolism has long been a hallmark of AD, it
has been predominantly considered a consequence of neuronal loss and synaptic failure. Relatively little
attention has been paid to the potential impact of changes in cerebral energy metabolism early in the
pathogenesis of disease despite compelling epidemiological evidence that obesity, insulin resistance, and type
2 diabetes are all risk factors for the development of neurodegenerative diseases such as Alzheimer's disease.
We have recently shown that obesity and higher levels of non-esterified fatty acids (NEFA) are associated with
blunted cerebral glucose transport.
APOE genotype is one of the primary risk factors for AD. Given the important role that APOE has in
lipid homeostasis in the periphery and the brain and the fact that several studies have shown that APOE4
carrier status directly affects fatty acid metabolism, the goals of this R21 are to determine whether and how
APOE status can modulate the relationships between obesity, NEFA, and brain glucose transport. The findings
from these studies will have important implications for ADRD. The central hypothesis is that cognitively normal,
relatively young individuals who carry at least one APOE4 allele will have decreased cerebral glucose transport
capacity measured using 1H magnetic resonance spectroscopy brain scanning compared to age and BMI
matched control subjects who are homozygous APOE3/3 and that this will be potentiated by obesity and
exposure to high circulating fatty acids.

Public health relevance
Project Narrative Despite great advances in understanding the pathogenesis of Alzheimer's disease and its related dementias (ADRD), effective treatments still remain elusive and most promising therapies have failed to translate from animal models into humans. There is a large body of evidence that obesity and insulin resistance as well as APOE genotype are all risk factors for the development of Alzheimer's disease. The main goals of this R21 proposal is to determine whether and how APOE status, which is one of the major risks for AD, can affect the relationships between obesity and brain glucose transport as measured by magnetic resonance spectroscopy in the human brain.